NNLM Region 6 Regional Medical Library

The Program Core focuses on the following four aims: community-based outreach, workforce
development, technology access, and evaluation. Region 6 recognizes the importance of utilizing
community-driven approaches to engage underrepresented populations across the Region. A
core focus of Region 6’s community-based outreach plan will be an enhanced subaward program
for outreach to underrepresented populations. This program will provide targeted outreach to
Medically Underserved Areas (MUA), collaborations with the Region’s Advisory Groups and
Partner Outreach Program, and oversight by the Community Outreach Coordinator. The goal of
this program will be to foster meaningful engagement between Network members and build
capacity and trust through community-led initiatives. Awards made as part of this program will
have a direct impact on NNLM’s goals to promote health literacy and address health equity
through information. A health literacy summit will also be coordinated by the RML to further
build capacity across the Region. Beyond the health literacy summit, the RML is structured to
support a diverse workforce with various training needs. An education and outreach team will
develop and deliver trainings and other programming activities for librarians and library and
information science students; public health and other health professionals; and public librarians
and staff. Each target audience will require coordinators to assess, develop, deliver, and evaluate
activities to ensure the needs of NNLM’s diverse audiences are being met. Funding
opportunities will be offered to support professional development and establish relationships
across NNLM members. Funding support will also be made to organizations that operate in
MUAs and struggle with access to broadband internet. As part of its technology improvement
plan, Region 6 staff will also seek partnerships with organizations across the Region that can
further address digital inequities by incorporating digital health components. The RML will be
guided by a logic model, to be developed in collaboration with the NNLM National Evaluation
Center, and continuous evaluation throughout the five-year cooperative agreement will enable
data-driven decision-making regarding programming activities.

Public health relevance
None required per RFA